Human Exposure Modeling for PBDE Derivatives

DESCRIPTION (provided by applicant): This project will provide important information on dietary vs. workplace dust exposure to PBDEs by comparing blood levels between two high-exposures but distinct occupations - E-waste recycling and commercial fishing. Added relevance of the project comes from addressing a strategic goal outlined in the National Occupational Research Agenda for improving the health of commercial fishermen by measuring exposures to harmful chemicals of marine origin.

Public health relevance
PUBLIC HEALTH RELEVANCE: Domestic electronic waste (E-waste) recycling is a rapidly expanding occupation. However, it is unclear to what extent occupational exposure to PBDEs and the more toxic hydroxy analogues is occurring in E-waste workers and whether environmental as opposed to biological monitoring accurately reflects exposure. Confounding variables such as biotransformation and multiple exposure pathways within and outside the workplace hinder assessments of occupational exposure. Therefore, the goal of this project is to better understand the importance of occupational exposure to current-use polybrominated diphenyl ethers (PBDEs), their hydroxy- and methoxy PBDE analogues and non-PBDE flame retardants. We will recruit a total of 120 volunteers from the Puget Sound region, 40 of which are commercial or subsistence fisherman, 40 electronic recycling workers and 40 office workers from professions requiring traditional 8-hr indoor workdays. Dietary information will collected, including seafood consumption, during a 14-day period and then each volunteer will be asked to donate a blood sample for chemical analysis of more than 90 different PBDEs and structurally related compounds. We will also collect dust samples from each volunteer's place of work, which will also be analyzed for PBDE content. Formal statistical analysis of the analytical results will be conducted to determine whether a correlation exists in the plasma concentrations of individual PBDEs or the sum of the various organobromine chemical classes identified and PBDE content of workplace dust or dietary habits. __SpecificAimsTextDelimiter__ Specific Aims Polybrominated di-phenyl ethers (PBDEs) and other structurally related brominated compounds are used as flame retardants and have become ubiquitous environmental contaminants. The two most important routes of human exposure are from contaminated food and contact with dust found in households and workplaces (Frederiksen et al. 2009). Direct exposure to PBDEs can also occur as a result of airborne release from furniture and computer products treated with flame retardants. Some occupations such as electronic waste (e-waste) recycling have recently been recognized as a potential high-exposure occupation due to the high levels of PBDEs measured in dust at these sites (Schecter et al. 2009). Human exposure to PBDEs is a concern due to effects on thyroid homeostasis and developmental effects documented in animal models. Some PBDEs such as the tetra, penta and hexa bromine substituted forms have been demonstrated to be biotransformed in vitro by rodent and human liver tissue, which complicates assessment of PBDE health risks, as a variety of PBDE derivatives, notably hydroxylated PBDEs (OH-PBDEs) may be formed (Stapleton et al. 2009; Erratico et al. 2011). Certain OH-PBDEs and PBDE-O-methyl esters (MeO-PBDEs) are also marine natural products and it is unclear although likely, that marine fish and shellfish, which bioaccumulate these compounds serve as a vector for human exposures. Mounting evidence indicates that OH-PBDEs are the most toxicologically potent form of PBDEs that disturb thyroid function and are hypothesized to be potent agents of neurological effects (Legler and Brouwer 2003; Li et al. 2010). OH-PBDEs have also been shown to be potent inhibitors of enzymes involved in steroidogenesis and may have anti-androgenic effects (Canton et al. 2006; Canton et al. 2007). Also, demethylation of some MeO-PBDEs has been demonstrated in both fish, and mammals (Wan et al. 2010). Thus, it is possible that MeO-PBDEs are converted to the OH-PBDE form in humans (Qiu et al. 2009), raising concern that consumption of fish and shellfish of marine origin high in OH- PBDEs or MeO-PBDEs may ultimately be a significant source of the more toxicologically active form of PBDEs. With regard to occupational exposures, domestic e-waste recycling is an occupation expected to grow, particularly in light of anticipated legislation and/or more stringent enforcement of existing laws to restrict export of unprocessed e-waste (http://e-stewards.org/). However, it is unclear to what extent occupational exposure to PBDEs and the more toxic hydroxy analogues is occurring in e-waste workers and whether environmental as opposed to biological monitoring accurately reflects exposure. Commercial and subsistence fishing are recognized as occupations that promote the highest levels of fish consumption relative to the U.S. average (Harris et al. 2009; Holloman and Newman 2010). Thus, e-waste recycling and commercial fishing represent occupations that can expose workers to the highest levels of either the anthropogenic PBDEs or naturally occurring PBDE analogues. Comparison of exposures between these two occupations will improve our understanding of the extent of PBDE, OH-PBDEs and MeO-PBDEs exposures and whether environmental as opposed to biological monitoring is adequate for assessing exposure. The hypotheses to be tested in this proposal are: 1. Relative to the general population, electronic recycling workers and commercial / subsistence fisherman receive the highest exposure to anthropogenic and/or naturally occurring PBDE's, respectively. 2. Because of the source differences in PBDE exposure (synthetic vs. marine), significant differences will exist between electronic recycling workers and commercial / subsistence fisherman in the PBDE, OH-PBDE and MeO-PBDE concentrations in plasma. The Specific Aims of this project are: 1) Recruit a total of 120 volunteers from the Puget Sound region, 40 of which are commercial or subsistence fisherman, 40 electronic recycling workers and 40 office workers from professions requiring traditional 8-hr indoor workday and perform quantitative analysis of PBDEs, OH-PBDEs, MeO-PBDEs and selected novel BFRs in blood plasma collected from the volunteers. A workplace dust sample will also be collected from volunteers in the e-waste recycling and indoor occupations. 2) Statistically compare PBDE congener profiles among the volunteers and assess the importance of occupational exposure and dietary habits in determining plasma concentrations of PBDEs and OH- PBDEs, MeO-PBDEs.